A pilot test of a brief eHealth parent-focused prevention intervention with parents referred from primary care clinics

ABSTRACT
Evidence-based parent-focused prevention programs prevent future mental illness but are not widely available
nor well-attended. To address this this critical gap, research must test more accessible delivery strategies.
Thus, the long-term goal of this study is to prevent significant behavioral health problems by increasing the
reach and accessibility of an evidence-based parenting program, GenerationPMTO (GenPMTO). GenPMTO
has been rigorously tested with in-person delivery; however, logistical barriers like a large time-commitment
and the need for childcare limit engagement in in-person parenting programs. Delivering programs online (i.e.,
eHealth) can overcome these barriers, increasing feasibility for parents. To increase reach, these programs
must be paired with frequently-accessed service settings. Primary care clinics are frequently accessed and
trusted settings; however, primary care personnel are not trained to address behavioral health or parenting
topics and pediatric referrals are often not made or completed. To integrate parenting programs with primary
care, training for primary care personnel and a well-defined referral process are needed. Therefore, this study
has two objectives: In chronological order, the first objective is to develop (Aim 1) and pilot test (Aim 2) a
referral process and a brief communication skills training for primary care providers to equip them to effectively
refer parents to eHealth GenPMTO, thereby increasing reach. Aim 1 uses an expert consensus method to
develop a feasible training and referral process. Aim 2 is a test of the acceptability of the referral process and a
pilot test of the training; primary care personnel (n=35) will be randomized to receive the training or a control
condition in which they receive written information about referring parents to GenPMTO therapists.
Acceptability, appropriateness, and feasibility of the training and referral process will be evaluated through a
mixed methods approach. The collaborating clinics in this study are part of a Federally Qualified Health Center,
facilitating reach within an under-served population of parents. The second objective of the study is to pilot test
the effectiveness of brief eHealth GenPMTO (Aim 3) within a primary-care-referred population. Although
GenPMTO has been rigorously tested, a brief eHealth version has not been tested, nor has GenPMTO been
examined for effectiveness among a primary care population. In Aim 3, n=60 parents referred by their primary
care provider (which occurs in Aim 2) will be assigned to GenPMTO or a single-session control condition in
which they are directed to existing parenting resources. Parents of 3-5-year-old children with moderate
behavioral concerns will be eligible for referral. Pilot effectiveness outcomes include parenting behaviors and
child externalizing and internalizing symptoms. Acceptability, appropriateness, and feasibility of brief eHealth
GenPMTO will be evaluated through a mixed methods approach. This study lays groundwork for a fully-
powered hybrid effectiveness-implementation trial.

Public health relevance
NARRATIVE The proposed research is relevant to public health because it tests innovative strategies to increase the reach and feasibility of an evidence-based parent-focused prevention program, while maintaining effectiveness of the program to prevent significant mental health problems. This study will inform the next stages of this program of research as well as provide valuable knowledge that can be immediately useful to others implementing prevention programs within primary-care-based populations.